Community Engagement Core

COMMUNITY ENGAGEMENT CORE (CEC)- PROJECT SUMMARY
The Community Engagement Core (CEC) will achieve the following: 1) engage with communities to understand
their environmental health concerns; 2) conduct research that reflects community needs and priorities and; 3)
evaluate the ability of SRC research to prevent or reduce exposures to polycyclic aromatic hydrocarbons
(PAHS) and alkylated PAHs (a-PAHs). The CEC will interweave expertise at Oregon State University and the
Swinomish Indian Tribal Community (SITC). The CEC is committed to building lasting Indigenous-Academic
partnerships and supporting new methods for building collaborations. One avenue is by providing training to
SRC investigators and trainees via Sense of Place seminars and forming the Indigenous Research Network.
This work culminates in a Center-wide Data Sharing Workshop, wherein the CEC will lead an effort to
consolidate best practices for building and maintaining Indigenous-Academic partnerships, to include
improving research ethics training, templates for data and material sharing and ownership agreements, and
memorandums of understanding. Additionally, the CEC works closely with all SRC projects and cores to
provide training opportunities and support partner-engaged research and engagement. The CEC integrates
strongly with Research Translation (Admin Core) to disseminate Center-wide research and ensure that the
report-back of research results is conducted in an appropriate manner. Overall, the CEC conducts research
within a community-engaged framework, which facilitates and supports a personalized approach to all aspects
of research, from initiation to application of research to prevent exposure. These foundational best practices
underpin the following CEC projects. The CEC will partner with Coast Salish Indigenous communities to
characterize exposure to PAHs and a-PAHs in the diet (Coast Salish Clam Garden Sampling Study) and in the
air (Coast Salish Wildfire Smoke Exposure Study). To facilitate informed risk assessment, the CEC will work
with other SRC investigators to build a user-friendly Indigenous Risk Assessment Calculator. Values from the
calculator will be used at the state level to better understand risk from consumption of contaminated clams. In
support of informed risk assessment, the CEC will lead a working group to develop guidelines for risk
assessments that incorporate non-chemical stressors with a focus on Indigenous exposure scenarios and
exposure routes. To expand understanding of best practices within Indigenous-Academic partners, the CEC
will support the continued offering of the Tribal Environmental Health Summit, to share and broaden expertise
in environmental health. Across the lifespan of the project, the CEC will conduct ongoing formative evaluation
to assess the impact of the research on informing prevention at the individual, familial, and community-level.

Public health relevance
NARRATIVE – COMMUNITY ENGAGEMENT CORE The Community Engagement Core facilitates and conducts community-engaged research with Indigenous communities and communities impacted by Superfund and toxic waste sites. The CEC seeks to learn from and learn with communities, Indigenous partners, and regulatory and health agencies to identify environmental health priorities and inform appropriate prevention and intervention activities.